Functional role and therapeutic potential of hedgehog signaling in tendon-to-bone repair

Summary
Approximately 30% of U.S. adults suffer from tendon and ligament injuries, which frequently occur near
insertion sites into bone (i.e., entheses) and do not spontaneously heal. Growth and development studies have
demonstrated a critical role for hedgehog (Hh) signaling in driving zonal enthesis formation but it's role in adult
enthesis repair is largely unknown. Zonal enthesis formation involves anchoring collagen fibers, synthesizing
proteoglycan-rich fibrocartilage, and mineralizing this fibrocartilage. Hh promotes this fibrocartilage formation.
Unfortunately, studying this pathway in traditional tendon-to-bone repair has been a challenge since these
repair models do not sufficiently anchor collagen fibers to bone, much less produce zones of fibrocartilage.
Conversely, ligament reconstructions, where a tendon graft is placed through bone tunnels, can produce zonal
attachments. Therefore, ligament reconstruction models, such as the anterior cruciate reconstruction model
proposed in this application, can be employed to study the mechanisms that regulate zonal tendon-to-bone
repair in the adult. This proposal will address this gap in knowledge by targeting the hedgehog pathway
genetically and pharmacologically during tendon-to-bone repair following ACL reconstruction in novel
transgenic mouse models. We will define the roles of the hedgehog pathway in specific stages of the repair
response from the expansion of the progenitor pool to production of fibrocartilage and bone within zonal
tendon-to-bone attachments during the tunnel integration process. By modulating the pathway
pharmacologically, we will determine the potential for this pathway to be targeted in a translational fashion that
could lead to novel therapies in the future. Our central hypothesis is that the Hh pathway is a critical positive
regulator of zonal enthesis formation in the adult and therefore stimulation of the pathway will improve tendon-
to-bone repair.

Public health relevance
Narrative Injuries to tendons and ligaments make up almost half of all musculoskeletal injuries yet the signaling pathways that regulate tissue formation during development and following injury remain poorly understood. This proposal seeks to fill this gap in knowledge using a series of novel mouse models to elucidate the functional role of hedgehog signaling in tendon-to-bone repair following anterior cruciate ligament reconstruction.